CPH - Project

CANCER CONTROL AND POPULATION HEALTH (CPH) – PROJECT SUMMARY/ABSTRACT
The goals of the Cancer Control and Population Health (CPH) Research Program are to comprehensively
investigate cancer etiology and disparities and to develop and implement interventions that reduce the burden
and improve the outcomes of cancer in the University of Virginia Cancer Center (UVACC) catchment area and
beyond. With significant institutional investment, the CPH program has enjoyed significant growth in the last
five years and has matured into a fully developed scientific program. Program members have expertise in
cancer epidemiology, behavioral medicine, health services research, quality of life research, and community-
engaged interventions to address the following two aims: 1) Identify and investigate a confluence of biological,
behavioral, and socioeconomic factors and mechanisms driving disparities in cancer risk and outcomes; and 2)
Develop novel interventions and conduct implementation research in diverse populations to reduce cancer risk
and cancer disparities. CPH has 2 co-leaders: L. Li is an expert in cancer etiology and health disparities
research and Anderson's extensive health services research focused on cancer health disparities in low
income and rural populations is ideally suited for the largely rural population we serve. The Program consists of
26 members, 16 of whom are new to UVA or the UVACC since the prior renewal, from 9 departments and 2
schools. This highly effective Program has successfully created synergy among the Members and inter-
programmatic and across-institutional collaborations. CPH Members are principal investigators of grants
totaling $6.38M direct costs of peer-reviewed funding, of which $2.19M is from NCI and $4.19M is from other
peer-reviewed sources. CPH is composed of highly productive and collaborative members with 306 total
publications in the last grant period. Of these, 9% have an impact factor of 10 or greater, 37% are intra-
programmatic, 13% are inter-programmatic with other UVACC Programs, and 60% are collaborative with other
NCI Cancer Centers. The overall research strategy of the CPH Program is to reduce the risk and burden of
cancer in the catchment area through identification and discovery of factors related to cancer risk, improving
access to prevention and treatment, and improving general health and preventive behaviors. This strategy
focuses on the high-priority areas of the UVACC including cancers related to tobacco and obesity (especially
lung and colorectal) as demonstrated through Program Member research seeking to identify new determinants
of cancer risk, behavioral risk reduction, and treatment.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.